Purchase College Bridges to the Baccalaureate Program

Project Summary
Purchase College, State University of New York (SUNY) is partnering with seven SUNY community
Colleges (Dutchess, Rockland, Orange, Nassau, Sullivan, Ulster, and Westchester) to enhance the
diversity of the biomedical/behavioral research workforce by providing successful strategies to increase
the number of students from underrepresented groups (primarily underrepresented minorities) who
successfully transfer and complete baccalaureate degrees and enter the workforce or go on to post-
baccalaureate work. The new Bridges Program builds upon the success of the current program,
established in 2000, that has achieved a 77% transfer rate and a 61% bachelor degree completion rate
in biomedical and behavioral sciences. In addition, 28% of these students have gone on to post-
baccalaureate work. The new Bridges Program has significant changes that will provide an expanded
summer research experience along with a two week-long series of courses for skills development
designed to increase student engagement and student capacity for learning. The new program also
provides opportunities for Purchase and community college faculty to develop courses that are
inclusive of all students. In addition, students returning to their two-year institutions for their second-
year will have the opportunity serve as tutors and mentors for other underrepresented students. Bridges
students will also be encouraged to participate in a second intensive summer research experience at
already designated sites including other SUNY campuses and Albert Einstein College of Medicine (see
Letters of Support). In order to ensure leadership support for these new initiatives, the Bridges
Program will continue the meetings of Presidents and Chief Academic Officers of all partner institutions
to enhance the infrastructure of communication between academic leadership and faculty around
issues of student outcomes and program challenges. This will ensure support for the program and
sustainability beyond the grant period. The external evaluator will conduct both formative and
summative evaluation activities that are designed to inform programmatic decisions about “what’s
working” and provide evidence about the impact of program initiatives on participants’ skills and
abilities. The Bridges Program will improve upon the transfer rate, increase the current bachelor’s
degree completion rate, and increase the percentage of students who go on to post-baccalaureate
work.

Public health relevance
Public Health Relevance Established in 2000, Purchase College’s 'Bridges to the Baccalaureate Program' provides a six-week summer research experience to qualified minority, disadvantaged, or disabled students. Beyond the research experience, the program features community-building activities, workshops for student development, and instruction in Responsible Conduct of Research and the use of e-Portfolios.